Testing tailored text reminders and financial incentives to enhance antidepressant adherence for depressed adults in primary care

ABSTRACT
Improving outcomes for adult depression in primary care is a leading health care priority and
antidepressants are a cornerstone of evidence-based treatment. However, patient non-adherence and
discontinuation are common. The proposed study examines use of modest financial incentives in conjunction
with tailored text message reminders to determine the most effective and cost-effective support for establishing
consistent antidepressant medication taking routines to improve clinical outcomes of adult primary care patients
with depression.
We propose to conduct a 3-arm RCT (N=525, n=175 per arm) to compare with usual care the short-term
and extended effectiveness of two adherence support strategies for primary care patients with depression who
have been newly prescribed antidepressant medications. We will examine whether personalized daily text
messages with and without financial incentives improves antidepressant adherence and depression symptoms.
Adherence will be measured with a wireless pill bottle at 6 and 12 weeks and by assessment of electronic health
prescription records at 24 and 52 weeks. Depression symptoms will be collected via telephone by a trained
assessor at 6 and 12 weeks. Our Specific Aims are to:
1. Determine the relative effectiveness of 1) 12 weeks of personalized daily text reminders without financial
incentives (reminders alone), 2) 12 weeks of the text reminders paired with 6 weeks of financial incentives
(reminders and incentives), compared with 3) usual care, and with each other (non-inferiority). The
primary outcome will be symptom response on the PHQ-9 depression rating scale at 12 weeks.
2. Explore the effectiveness of each study intervention arm compared to usual care and to each other on
antidepressant adherence at 6, 12, 24, and 52 weeks, and whether these effects are moderated by
baseline financial security and adherence intentions. We also will assess whether the intervention effects
in Aim 1 are mediated by antidepressant adherence.
3. Use qualitative inquiry of antidepressant adherent and non-adherent study patients to explore
opportunities to maximize the effectiveness of the financial incentives and reminders to increase
antidepressant medication adherence.
Widespread problems with antidepressant adherence, especially during the early stage of treatment,
undermine the primary care treatment of depression. This study will test whether personalized daily text
messages grounded in behavioral economics principles alone or combined with financial incentives based on
contingency management principles improves depression outcomes. These two interventions are designed to
be readily adapted into primary care workflows through an automated patient-facing system to improve clinical
outcomes of adult primary care patients with depression.

Public health relevance
NARRATIVE Depression is a prevalent and burdensome public health issue and widespread problems with antidepressant adherence, especially during the early stage of treatment, undermine the primary care treatment of depression. This study will test whether personalized daily text messages alone or combined with financial incentives improves depression outcomes. Scalable patient-facing intervention strategies that target adherence barriers are needed to support the treatment of depression in primary care to improve medication adherence and reduce depression symptoms.